Pioglitazone-Metformin Combination Treatment for High Risk Oral Preneoplasia

Project Summary/Abstract
With stagnant cure rates, there is a severe unmet need for strategies to improve oral and all other types
of aerodigestive cancer survival. There are no robust chemoprevention drugs or other treatments for high
risk oral precancerous conditions or field carcinogenesis despite 40 years of clinical trial research. High
risk oral precancerous conditions (such as leukoplakia) represent a standard target for chemoprevention
interventions. Type II anti-diabetic agents, including pioglitazone and metformin, are promising cancer
prevention drugs for oral cavity preneoplasia that we have used in NCI sponsored clinical trials. They
have adequate safety and moderate efficacy in human trials, however, individually are likely not sufficient
to advance to large scale clinical trials. These agents have differing mechanisms of action which each
attack different events in oral carcinogenesis. In this project, we propose to conduct a phase IIa 12 week
clinical trial with combination BID pioglitazone-metformin (15mg-500mg) in oral preneoplasia patients.
We have assembled a consortium of clinics in Minneapolis/St. Paul MN for efficient accrual to this trial.
We will examine pharmacodynamic endpoints in specimens based on both the mechanisms of the
agents and how they may affect T cell subsets before and after treatment. Further, we will also analyze
leukoplakia specimens and adjacent normal mucosa specimens by RNA-Seq before and after treatment,
which will shed light on effects of the drugs as well as any putative “off target” effects. At the completion
of this project, we will have a better understanding of pioglitazone and metformin effects on oral
carcinogenesis, as well as, an early stage clinical trial which could be expanded to larger randomized
trials with a promising cancer prevention strategy for oral preneoplasia or other tobacco-associated
malignancies.

Public health relevance
Project Narrative There is an extreme unmet for drugs that can prevent oral cancer in high risk patients. This clinical trial will test a combination drug, pioglitazone-metformin, in patients at high risk for developing mouth cancer. The findings from this trial can ultimately result in a treatment that would be available for use in over 250,000 patients a year who are at high risk for oral cancer development or recurrences.